INHIBITION OF CYTOCHROME P450 ON THERAPY EFFECTS OF ANGIOTENSIN RECEPT BLOCKER

Evaluate the relative clinical importance of drugs that alter the activity of cytochrome P450 isoenzymes , CYP 3A4 and CYP 2C9 , on therapeutic effects of Losartan and Valsartan. Ongoing.